Small Molecule Inhibitors Against HPV-Induced Orophageal Cancers

PROJECT SUMMARY/ABSTRACT
Human Papillomavirus (HPV) is the major cause of head and neck squamous cell carcinomas; most
oropharyngeal (75%) and other head and neck cancers are caused by chronic HPV infection. Metastatic HPV-
associated cancers are minimally responsive to current treatments and uniformly fatal. The most recent
American Cancer Society annual statistics for oral/oropharyngeal cancers in the U.S. indicate 54,540 new
diagnoses and 11,540 deaths. Novel therapies are therefore sorely needed.
HPV-associated cancer cells require direct dysregulation of cells through viral E6 and E7 oncoproteins, which
are indispensable for tumorigenesis. These proteins are essential for ongoing tumor cell survival, and therefore
serve as ideal therapeutic targets. Knockdown of E6 or E7 using siRNA in HPV-transformed cells results in
apoptosis.
This pilot R21 project describes plans to screen for druggable small molecule antagonists of HPV E6 or E7
oncoproteins. The overall strategy will be to screen small molecule libraries for compounds that cause specific
death of tongue cancer squamous cell lines with HPV, but not those without HPV:
o Aim 1: To create tongue carcinoma cell clones differing in HPV status and fluorescence color.
o Aim 2: To screen small molecule libraries for drug candidates causing HPV-specific cell death.
o Aim 3: To test the function of drug candidates to induce death of other HPV-transformed cells.
Successful completion of this project would identify drug candidates that induce apoptosis of HPV-transformed
oral cancer cells through interference with E6 or E7.

Public health relevance
PROJECT NARRATIVE Human Papillomavirus (HPV) is the major cause of oropharyngeal squamous cell carcinomas, accounting for over 75% of cases. This pilot project will screen for small molecule inhibitors of the HPV-mediated malignant transformation, with the goal of identifying molecular candidates for drugs to treat HPV-associated oropharyngeal cancers, which are currently untreatable once metastatic.